Innate immunity and ischemic stroke

Abstract
The immune system is closely involved in all stages of ischemic stroke-induced brain damage
and tissue repair. However, treatments aimed at modulating inflammation have not been
successfully translated into the clinical settings yet. Therefore, the development of new anti‐
inflammatory therapies, especially those targeting upstream inflammatory signaling in ischemic
stroke is necessary and urgent. Transposable Elements (TEs) alter gene expression via
transposition. Dysregulation of TEs plays a critical role in pathogenesis of neuroinflammation. TE
RNA activity is regulated by adenosine deaminase acting on RNA 1 (ADAR1) which is the “Editor-
in-Chief” of cytoplasmic innate immunity and thus plays a key role in regulating innate immunity
to dampen interferon-mediated response. Our preliminary data indicate that brain ischemia
caused ADAR1 dysfunction, leading to TE RNA editing alteration. Dysregulated TE RNAs
activated RNA sensing molecules which in turn triggered interferon-stimulating genes (ISG).
ADAR1 mutation triggered a robust production of MDA5 and activation of ISG signaling and
aggravated brain damage and neuroinflammation in murine ischemic model of middle cerebral
artery occlusion (MCAO). Bocking RNA sensing signaling by deleting MDA5 effectively prevented
inflammation. This specific innate immune pathway connects ADAR1 to the dysregulated TE
RNAs and neuroinflammation following brain ischemia. The central hypothesis to be tested is
that ADAR1 protects against ischemic brain injury by suppressing neuroinflammation
through blocking the RNA sensing signaling pathway of innate immunity. The following
three Aims are proposed: Aim 1: Characterize ADAR1 RNA editing profile in brain injury in MCAO
model. Aim2: Test whether ADAR1 protects against ischemic brain injury by suppressing
neuroinflammation through blocking MDA5/IRF7/IFN signaling pathway in MCAO model. Aim 3:
Test whether targeting ADAR1 signaling can ameliorate neuroinflammation and brain injury and
rescue behavioral abnormalities in MCAO model. The role of ADAR1 in brain ischemia has never
been investigated. This study is the first to link RNA editing and neuroinflammation in the context
of brain ischemia and will provide new insights on the role of innate immunity in ischemic brain
injury. Our proposal paves a foundation to a new concept of targeting upstream inflammatory
signaling to treat ischemic stroke and neurological diseases that involve inflammation.

Public health relevance
Stroke causes neuroinflammation, which plays a critical role in all stages of ischemic stroke- induced brain damage and tissue repair. We found that special “jumping genes” called transposable elements (TE) are a major player in triggering neuroinflammation following stroke. The activity of TEs is regulated by an enzyme called adenosine deaminase acting on RNA (ADAR1). We will investigate the role of TE in ischemic brain injury and further dissect the mechanism underlying TEs’ triggering of neuroinflammation in an animal model of ischemic stroke. We will investigate whether a novel therapy targeting ADAR1 will attenuate ischemic brain injury and enhance neurological function. If successful, this project will provide a novel anti- inflammatory therapy for stroke, which is the second most common cause of death worldwide and is the leading cause of long-term adult disability in the United States.